Development and assessment of an HIV disclosure intervention for men

PROJECT SUMMARY
Background: Disclosure of HIV is a key step in prevention, however, few evidence-based resources exist to support HIV disclosure among men with HIV. Candidate: My long-term goal is to become an independent, NIH-funded clinical researcher dedicated to interventions to support HIV and sexually transmitted infection prevention and treatment in resource limited settings. Research: The goal of this proposal is to develop and test an HIV disclosure intervention focused on men with HIV meeting the following eligibility criteria: with sexually transmitted infection symptoms who are either not accessing antiretroviral therapy or are accessing antiretroviral therapy but without viral suppression. In Aim 1, I will identify the unique HIV disclosure needs and preferences to support HIV disclosure through in-depth qualitative interviews with up to 30 men with HIV meeting eligibility criteria. In Aim 2, I will utilize the findings from Aim 1 to adapt interventions with HIV disclosure components in order to develop a novel HIV disclosure intervention focused on men with HIV. The intervention will be iteratively refined through focus group discussions with up to 20 participants, their sexual partners, and a community advisory board. In Aim 3, I will recruit 70 men with HIV meeting eligibility criteria for participation in a randomized controlled trial to pilot test the intervention against an attention-matched control group. Participants will be encouraged to bring their sexual partners for study enrollment and HIV testing and counseling. Up to 15 men with HIV and their sexual partners will be invited for qualitative interviews. I will measure the primary outcomes of acceptability and feasibility by mixed methods. Training: To achieve my aims and gain research independence, I require additional training in: 1) behavioral science theory for behavioral intervention development and assessment 2) methods for behavioral intervention development, and 3) advanced behavioral clinical trial analysis. Based on my previous research experience and success, support from an exceptional mentoring team, strong institutional commitment, and an innovative research plan, I am well-positioned to become an independent clinical investigator focused on HIV and sexually transmitted infection prevention and treatment in resource limited settings.

Public health relevance
PROJECT NARRATIVE Men consistently lag behind women along each step of the HIV care cascade and contribute to HIV transmission among women. HIV disclosure is key to HIV prevention; however, few evidence-based resources exist to support HIV disclosure among men with HIV. I propose to develop and pilot test an HIV disclosure intervention to support men with HIV with symptoms of sexually transmitted infections who are either not accessing antiretroviral therapy or are accessing antiretroviral therapy but without viral suppression, with the goal of engaging men in care and decreasing partner HIV transmission.